Perceptual And Motor Decisions In The Primate Brain

My research interest is to understand how subjective perception and voluntary motor actions emerge from brain activity. My main approach is to record neural activity in the brains of monkeys performing various visual search and forced-choice discrimination tasks. Most of my research has focused on the frontal eye field (FEF), which is located in the prefrontal cortex and participates in the transformation of visual information into commands to move the eyes. The goal this project is to understand how we make perceptual decisions, choose where to direct gaze and to understand the neural basis of directed visual attention. [unreadable] [unreadable] One of the outstanding questions of cognitive neuroscience is how we are able to focus visual attention on specific objects and locations without moving our eyes. Multiple lines of evidence suggest that developing oculomotor commands originating from the FEF mediate spatial attention. We tested this hypothesis by recording from visual and saccade related neurons in the FEF of monkeys performing covert visual search tasks without eye movements. We found that the visually responsive neurons, and not the saccade-related neurons, are the source of attention signals in FEF (ref. 1). In another study, we addressed the question of how cognitive processes control spatial attention in the absence of visual input. We recorded frontal eye field activity in monkeys trained to perform a difficult discrimination task in which the monkeys attended the locations of the visual stimuli to be discriminated before they actually appeared. We found that most FEF neurons exhibited elevated activity when a cue informed the monkey that a stimulus would appear. This anticipatory attention-related activity in FEF occurred without any visual stimulation and was not related to motor processes (ref. 2). Together, these studies demonstrate that stimulus-driven and cognitively-driven spatial attention signals are present in FEF and are independent of saccade command signals. Therefore, FEF probably serves an important role in controlling visual spatial attention in addition to its well known role in saccade production.[unreadable] [unreadable] We also examined the neural basis of how we adjust our behavior when confronted with unexpected events that render our current actions inappropriate (ref. 3). We recorded saccade command signals in the FEF of monkeys performing a visual search task in which the target of a search unexpectedly changed position with one of the distractors. Consequently, some saccades were directed in error to the original target location and were followed frequently by unrewarded corrective saccades to the final target location. We found that saccade-related activity producing corrective saccades on error trials begins before visual afferent signals and error recognition signals could respond to the changed image following the execution of the error saccade. These observations provide direct evidence for a rapid error correction mechanism before an errant behavior can be detected by the visual system or by the error monitoring system. [unreadable] [unreadable] These studies have extended our understanding about the frontal eye field far beyond its familiar role in controlling eye movements. With this knowledge we can design experiments to investigate the flow of sensory information through the brain as it is transformed into perception and action. This work helps us understand the mechanisms of how the brain focuses attention to make perceptual decisions and guide behavior, which is necessary to be able to understand and treat attention-related disorders in humans.